Maternal Heart Health Starts at Home (MomHeart): Targeting Place-Based Social Determinants to Improve Pregnancy and Postpartum Cardiovascular

ABSTRACT
Adverse cardiovascular health (CVH) is the leading cause of pregnancy-related deaths in the US, which have
increased 140% over the past three decades. Adverse CVH disproportionately affects pregnant individuals
who experience adverse social determinants of health (SDOH) and directly contributes to marked disparities in
maternal CVH. SDOH should be understood as a multi-dimensional construct to be measured and intervened
upon at multiple-levels, including both individual- and neighborhood-level SDOH (iSDOH, nSDOH). An
individual’s lived experience, which are shaped by experiences of both iSDOH and nSDOH, directly impacts
CVH across the lifespan, including during pregnancy and the postpartum. Yet, during this important moment in
a woman’s life, the relationship of SDOH factors with adverse CVH, including clinical factors, adverse
pregnancy outcmes (APOs), and ultimately, cardiovascular disease (CVD) remains uncertain. In addition,
nSDOH remain poorly characterized and understood during pregnancy and the postpartum. Healthy People
2030, professional recommendations, and NHLBI’s Strategic Vision Implementation Plan emphasize that
effective population-level structural interventions and policies to improve CVH requires a mechanistic, holistic
and integrated understanding of SDOH factors. Efforts to quantify the influence of SDOH factors on CVH have
largely failed because the causal pathways are numerous, interconnected, and complex. A promising approach
to test the inter-relationships of multiple SDOH factors over time is a polysocial risk score. We will harness the
prospective, nuMoM2b nulliparous pregnancy cohort (nuMoM2b) and the ongoing postpartum follow-up
nuMoM2b Heart Health Study (HHS). This contemporary, generalizable, and deeply phenotyped population
includes >10,000 individuals during their first birth experience from across eight US centers. We will employ
contemporary theoretical frameworks, machine learning, advanced Bayesian methods, and participant-
engaged data walks to construct concepts, identify relationships, and shape future policy and multi-level
interventions addressing SDOH and maternal CVH. Our premise in MomHeart is that maternal CVH is spatially
patterned by multiple, intersecting socially-mediated factors in the peripartum period. We will accomplish three
complementary specific aims: 1: Determine associations of individual iSDOH and nSDOH with maternal CVH
(clinical factors, APOs, composite CVH, and predicted CVD risk), cross-sectionally and longitudinally; 2:
Examine the intersectionality of iSDOH and nSDOH through a polysocial risk score and examine the
associations between a polysocial risk score and maternal CVH; and 3: Conduct qualitative interviews with
active nuMoM2b-HHS participants with lived experience to elucidate perspectives on how SDOH patterns
discerned have had relevance to their own CVH and could serve as intervention points to improve maternal
CVH. MomHeart will shape the future of precise and targeted multi-level interventions and public health
policies to enhance the CVH of the highest risk pregnant and postpartum indivduals.

Public health relevance
PROJECT NARRATIVE Adverse social determinants of health in pregnancy and postpartum directly influence adverse maternal cardiovascular health across the lifespan, which includes adverse pregnancy outcomes, clinical risk factors, and ultimately, cardiovascular disease, which is the leading cause of pregnancy-related death in the US. MomHeart will leverage novel, interdisciplinary, and community-engaged epidemiologic approaches, innovative geospatial Bayesian models, and machine learning, to define the intersection of multiple, interconnected, and complex individual- and neighborhood-level social determinants of health through a polysocial risk score, and the association of this score with maternal CVH across the peripartum period. Given the increasing burden and devasting consequences of adverse social determinants on maternal CVH, MomHeart will provide the evidence to shape future multi-level interventions and policies that directly mitigate adverse social determinants of health to improve maternal cardiovascular health.